Improving Care Giver Adherence to Recommended Infant Care Practices

Project Summary/Abstract
The focus of this renewal application is to leverage the platform from which we successfully launched
the Social Media and Risk Reduction Training (SMART) study, a randomized trial using mobile health
(mHealth) strategies to improve caregiver adherence to American Academy of Pediatrics (AAP)-recommended
infant care practices related to safe sleep, and to enhance the reach by adding a culturally-sensitive prenatal
education component and specifically targeting low-income populations who are most at risk for sleep-related
infant deaths. SMART was proposed to design, implement, and assess the effectiveness of interventions to
prevent Sudden Infant Death Syndrome (SIDS) and unintentional injury-related infant deaths associated with
the sleep environment. These deaths, which we will refer to as sleep-related deaths, remain the leading cause
of postneonatal death in the United States, with ~3500 deaths each year. Many of these deaths are preventa-
ble with improved adherence to AAP safe infant sleep guidelines.
A key finding from SMART was that nursery-based education alone was not effective, but a technology-
based mHealth messaging intervention was – mothers receiving safe sleep mHealth messages had ~10 per-
centage point higher rates of following safe sleep practices. Our proposed SMARTER (Social Media and Risk
Reduction Teaching- Enhanced Reach) study is the natural next step towards the full translation into practice
of SMART. The SMARTER study plans a 4-arm pragmatic RCT in which 2500 pregnant mothers recruited at
Special Supplemental Nutrition Program for Women, Infants, and Children (WIC) programs in 2 states (MA and
VA) are randomly assigned to a combination of safe sleep and breastfeeding mHealth interventions prenatally
and postnatally: 1) Safe Sleep Prenatal and Breastfeeding Postnatal; 2) Breastfeeding Prenatal and Safe
Sleep Postnatal; 3) Safe Sleep Prenatal and Postnatal; and 4) Breastfeeding Prenatal and Postnatal. This
combination of study conditions will allow us to evaluate message content, timing, and dose of uptake and
maintenance of safe sleep and breastfeeding practices through 6 months after birth. The primary aim is to as-
sess the effectiveness of the mHealth prenatal and postnatal interventions aimed at promoting safe sleep prac-
tices and breastfeeding. The secondary aim is to assess potential mediating factors that may explain the inter-
vention effects on infant care practices and inform areas for improving future intervention approaches.

Public health relevance
Project Narrative SIDS is the most common cause of infant mortality beyond the neonatal period, and adherence to safe infant sleep practices has been proven to reduce the risk of SIDS. If, as we believe, the proposed and relatively sim- ple to implement interventions improve adherence to safe sleep practice and breastfeeding recommendations, SMARTER would be expected to have the following important implications: 1) WIC centers and other healthcare providers nationally will adopt these mHealth strategies for safe sleep and breastfeeding education, leading to increased adherence to these infant care practices and resulting in fewer sleep-related deaths as well as other improved health outcomes related to breastfeeding; and 2) These methods will be used in inter- ventions for other health conditions, particularly those with racial/ethnic, educational or socioeconomic dispari- ties.